Longitudinal dynamics of protection after influenza infection and vaccination

PROJECT SUMMARY
Individuals’ adaptive immune responses are central to the epidemiology and evolution of influenza and the
effectiveness of influenza vaccines. It is therefore surprising that despite nearly 70 years of study, major
questions about the immune response to influenza remain unanswered. In particular, it is unclear how well
natural infection protects from reinfection with the same or related types and subtypes, how vaccination affects
protection against symptomatic and asymptomatic infections over time, and how protection varies with immune
history, age, individual, sex, and other factors. The two main obstacles to progress have been a shortage of
observations from the same individuals over time and a lack of modeling approaches that can accommodate the
complex, stochastic dynamics of infection and immune response replicated across individuals. The proposed
research takes advantage of an extraordinary influenza cohort and new methods for longitudinal modeling to
understand how protection to influenza infections of varying severity arises, and especially how it is shaped by
infection and vaccination history. The ongoing Nicaragua Pediatric Influenza Cohort Study (NPICS) has followed
thousands of children since 2011 and recorded their antibody titers, infections, symptoms, and vaccination
history to influenza. We will use these data to fit and evaluate a large set of stochastic, individual-level,
mechanistic, dynamical models to estimate the duration of protection and its dependence on exposure history
and other factors. First, we will estimate the duration of protection against reinfection with the same type or
subtype and evaluate its dependence on the order of early exposures and host and viral characteristics. Next,
we will measure the strength and duration of cross-protection between type and subtypes. Finally, we will
compare the dynamics of protection after natural infection to those after vaccination, including repeat
vaccinations. Our flexible modeling approach takes advantage of diverse data types and inference techniques
while allowing precise formulation of biological hypotheses mathematically. Its recent success with similar
longitudinal datasets of PCR-confirmed viral infections and influenza serology demonstrates feasibility.
Preliminary results suggest a role of exposure history on heterosubtypic infection risk. This work is poised to
advance basic knowledge on influenza and the development of immune memory, and it will provide a new set of
dynamical modeling tools for longitudinal data. This project will thus achieve NIH MIDAS objectives by advancing
the development of inference techniques and software for an important and growing type of data and by
expanding knowledge of an important host-pathogen dynamic. This work also directly addresses priorities
established by the NIH Strategic Plan for the development of a universal influenza vaccine, especially identifying
factors associated with the severity of influenza (objective 1.2) and improving understanding of how and when
exposure to influenza antigens shapes the response to infection and vaccination (objective 2.1).

Public health relevance
PROJECT NARRATIVE The development of protective immunity to influenza is of central importance to public health, yet little is known about how natural infections and vaccinations contribute to the development of protection against diverse influenza strains over time. This research uses observations from a large, longitudinal pediatric cohort to fit mathematical models to explain how protection evolves early in life. The results will contribute to fundamental knowledge of influenza epidemiology and the development of next-generation influenza vaccines.